Evaluating the role of the novel apoptosis inhibitor TRAILshort, in maintaining HIV persistence.

? DESCRIPTION (provided by applicant): The interplay between a pathogenic viral infection and the human host reflects a bi-directional interaction of host sensors (e.g. TLR, RIG, etc.) which detect virus infection, host effector mechanisms which eliminate infected cells (e.g. caspase activation, expression of death inducing ligands including Fas Ligand and TRAIL), and viral adaptations which attempt to subvert the host response (e.g. virally encoded apoptosis inhibitors e.g. EBV encoded BALF1, KSHV encoded vFLIP etc.). Experimental elimination of virally encoded apoptosis inhibitors enhances host cell clearance of virally infected cells, and reduces viral persistence - as examples: inhibiting BALF1 prevents EBV persistence, inhibiting LAT inhibits HSV1 persistence, and disrupting E6 or E7 inhibits HPV persistence. HIV infection can be sensed in human cells for example by IFI-16 sensing of accumulated reverse transcripts leading to caspase 1 dependent pyroptosis, or DNA-PK sensing of integrase mediated host DNA nicking leading to p53 dependent apoptosis. However these sensing mechanisms do not eradicate all HIV infected cells, and HIV is as a result, persistent. HIV is not known to encode a protein which antagonizes the hosts ability to eradicate infected cells, yet accumulating evidence suggests that HIV infected cells are more resistant to cell death that corresponding uninfected cells, through an as yet undefined mechanism TNF related apoptosis inducing factor (TRAIL) is a molecule whose principal function is as an effector of immune surveillance, and it has been implicated in the pathogenesis of malignancies, as well as viral infections including HIV. Concerning the role of TRAIL in HIV, considerable data indicate that TRAIL is dysregulated during HIV infection in vivo, and there is ample evidence that treatment of cells from ART suppressed HIV- infected patients with exogenous TRAIL, reduces the number of latently infected cells, as measured by undetectable levels of replication competent virus in quantitative co-culture assays. The current research proposal concerns a novel TRAIL splice variant, which we have discovered and named TRAILshort, which is produced during HIV infection in vitro and in vivo. TRAILshort binds to TRAIL receptor 2 (TRAILR2), yet does not transmit a cell death signal, whereas TRAIL binding to TRAILR2 rapidly results in apoptotic death. Moreover, expression of TRAILshort, prevents TRAIL from engaging TRAILR2, demonstrating that TRAILshort acts as a dominant negative inhibitor of TRAIL mediated killing. Because NK cells and CD8+ CTL kill target cells by TRAIL (in addition to other mechanisms such as Granzyme B), it follows that TRAILshort expression reduces both NK cell and CD8 T cell cytotoxicity. Our underlying hypothesis is that TRAILshort production during HIV infection prevents TRAIL dependent HIV clearance mechanisms which allows HIV infected cells to persist. This hypothesis is supported by novel preliminary data included in this application, where shRNA mediated knockdown of TRAILshort does not alter uninfected T cell survival, yet selectively enhances killing of HIV infected cells, thereby reducing HIV replication by 3.5 logs, and decreasing the number of cells containing HIV DNA. The long-term goal of our work is to fully understand and manipulate TRAILshort production in order that normal immune mechanisms can contribute to clearance of virally infected cells, thereby providing an additional tool with which to contribute towards a cure for HIV. This will be fully explored by: (i) studying the regulation of TRAILshort, in order to identify means of inhibiting its production. (ii) Optimize lentivirus knock down of TRAILshort in primary CD4 T cells from HIV infected patients, and test whether HIV reactivation with TRAILshort knockdown, plus or minus co-culture with autologous CD8 T cells, or NK cells, reduces HIV reservoir size ex vivo (iii) Evaluate TRAILshort expression in HIV elite controllers, partial controllers and non-controllers, and determine the association of TRAILshort expression with HIV reservoir size.

Public health relevance
PUBLIC HEALTH RELEVANCE: Recently, there has been great interest in developing novel strategies designed to cure HIV infection, using innovative strategies to inhibit HIV replication, o purge HIV from the cells within which it hides, and/or the augment the immune response to HIV, such that the host immune system can eradicate HIV infected cells. The research strategy employed in the current proposal is predicated upon a unique discovery made by our lab, wherein we have identified a new molecule produced by HIV infected cells which functions to antagonize the normal immune response to HIV. This protein that we call TRAILshort is produced by HIV infected cells, and it prevents HIV infected cells from dying after they come in contact with the cytotoxic molecule TRAIL, which is normally produced by CD8 T cells and NK cells of the immune system. TRAIL plays a critical role in eliminating malignant or virally infecte cells. It is therefore not surprising that TRAIL is upregulated in cells from HIV infected patients reflecting an immunologic response designed to eradicate HIV infected cells. However, it is clear that endogenous TRAIL alone is insufficient to kill HIV infected cells. Over the past decade, we have shown that (i) ex vivo administration of additional TRAIL is sufficient to eradicate HIV from HIV infected patients T cells (ii) that such TRAIL treatment does not cause quantitative or qualitative impairments in bystander T cell, B cell, or NK cell function and (iii) hat HIV infected patient PBMC produce TRAILshort which antagonizes normal TRAIL signaling. Now we have discovered that inhibiting TRAILshort allows the TRAIL which is already present to kill the HIV infected cells. Indeed, inhibiting TRAILshort with genetic approaches reduces HIV replication by ~ 3.5logs and reduces the number of cells which contain HIV provirus. In the current proposed research, we propose to develop ways of inhibiting TRAILshort in HIV infected patients and test these strategies impact on the selectively killing cells which contain HIV, ( while sparing cells which do not contain HIV), and evaluate how many HIV containing cells persist after TRAILshort inhibition. Ultimately these interventions will increase our understanding into novel approaches designed to cure HIV infection.